Mechanisms of cell fate specification by glycosylation

PROJECT SUMMARY
Cell fate is determined through a complex hierarchy of events that require tight regulation of signaling pathways.
Misspecification of cell fate can have detrimental effects on downstream developmental events, leading to tissue
mispatterning and disease. Key principles of cell fate specification remain unknown. Defining the mechanisms
that provide spatial and temporal precision to gene regulatory networks is crucial for understanding how cell
identity is established and can be leveraged to generate desired cell types for the repair of damaged or diseased
tissues. In previous work, the PI has identified protein glycosylation as an unexplored mechanism that regulates
cell fate. The long-term goal of the PI’s research program is to exploit the intrinsic plasticity of endothelial cells
to define the fundamental principles by which glycosylation determines the identities of differentiated cells. The
proposed R35 project will investigate two parallel cell fate decisions, representing four distinct cell types: artery,
vein, lymphatic, and hematopoietic stem/progenitor cells. It will harness the optical transparency of zebrafish
embryos to make highly quantitative measurements of these processes as they unfold naturally in vivo. It will
also leverage a first-of-its-kind list of glycoprotein candidates and its glycosylation sites that are misglycosylated
in a cell fate mutant. The overall objectives of this study are: 1) To decipher how glycosylation regulates the
functions of cell fate regulators; and 2) To determine how glycan composition dictates the choice of cell identities.
In Project 1, loss-of-function studies in zebrafish will reveal how five N-glycoproteins regulate the cell fate
transformation of arterial endothelial cells into hematopoietic stem/progenitor cells. Additionally, missense
mutations that prevent glycan attachment to these candidate proteins will be generated to assess the
requirement for glycosylation in their fate-determining functions. Project 2 will use a cell fate mutant as a tool to
test how glycosylation regulates the transformation of venous endothelial cells into lymphatic endothelial cell
progenitors. The experimental approaches will identify the glycosylation enzymes and glycan repertoire required
for this important fate decision, ultimately demonstrating that discrete glycans repertoires instruct endothelial cell
identity. This research is innovative in that it seeks to apply state-of-the art microscopy, genetic, and glycomic
technologies to characterize glycosylation-dependent mechanisms of specification for multiple clinically relevant
cell types in vivo. Using this process to compare cell fate decisions from a common lineage provides a rare
opportunity to define the universal and cell-specific mechanisms of glycosylation in cell fate regulation. The
proposed work is highly significant as the results have the potential to reveal new design principles of cell fate
specification, and thereby inform new strategies of cellular reprogramming, via glycoengineering, for therapeutic
interventions.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it will define the mechanistic functions of glycosylation in cell fate specification, which could inform new strategies of producing clinically relevant cell types for the repair of damaged or diseased tissues. Thus, this study is aligned with the NIGMS’s mission to increase our fundamental understanding of biological processes so to lay the foundation for advances in therapeutic interventions.